Activation of the niacin receptor HCAR2 to mitigate tau pathology

Abstract
Tauopathies are a group of devastating neurodegenerative diseases, such as frontotemporal lobar
degeneration (FTLD)-tau or Alzheimer’s disease (AD), that are characterized by the presence of pathological
hyperphosphorylated and misfolded aggregates of the microtubule-associated protein tau. There are no effective
treatments for tauopathies. Interestingly, it has been reported that higher intake of niacin (also known as nicotinic
acid) correlates with reduced risk of AD, which suggests that niacin may protect against pathogenic tau-induced
neurodegeneration and could be of therapeutic utility. Niacin can cross the blood brain barrier and directly
activate HCAR2 (GPR109A), a GPCR that is expressed in the brain selectively by microglia. HCAR2 activation
by niacin and other ligands have been demonstrated to elicit a protective microglial response and overall salutary
effects in different models of neuronal injury or neurodegeneration. However, an HCAR2-directed therapeutic
strategy has not been tested for tauopathies. We hypothesize that HCAR2 activation with niacin may be a
promising therapeutic strategy for tau pathology. Importantly, there are FDA-approved formulations of niacin,
which could potentially be rapidly repurposed for tauopathies in the clinical context.
We provide preliminary evidence that pathological tau induces HCAR2 expression by microglia. Inactivation of
Hcar2 in tauopathy mouse models leads to exacerbation of the disease, suggesting a protective effect of HCAR2.
Conversely, treatment with niacin reduced neuronal loss, motor deficits, tau phosphorylation, propagation and
seeding activity in these models.
Aim 1) Study the therapeutic potential of HCAR2 in tauopathy preclinical models We aim to establish
an effective therapeutic strategy for the treatment of tau pathology by activating HCAR2. The HCAR2 agonist
niacin will be delivered to pre-clinical tauopathy mouse models by enriched diet or oral gavage using the FDA-
approved formulation Niacin-ER. Furthermore, HCAR2 will be selectively inactivated in microglia cells in
tauopathy mouse models after disease onset. The effects of niacin treatment and Hcar2 deletion on tau
pathology will be assessed in PS19 mice and the effects on tau spreading will be analyzed in mice injected with
an AAV encoding pathogenic tau.
Aim 2) Determine the cellular mechanism subserving HCAR2 actions on tau pathology. We propose to
establish the cellular mechanisms and pathways underlying the role of HCAR2 on tau clearance using a
combination of pharmacological, genetic, and omics approaches. We postulate activation of HCAR2 induces the
clearance of pathogenic tau species by microglia, overall reducing the propagation of tau pathology. Microglia
cultures will be used to assess the role of HCAR2 on tau uptake, intracellular degradation, and release of
pathogenic forms of tau. Elucidating the mechanisms subserving HCAR2 actions will allow us to understand how
this therapeutic strategy can be further improved and identify novel potential pharmacological targets.

Public health relevance
Narrative There are no effective therapies to mitigate tau pathology, which is a hallmark of several neurodegenerative diseases, including frontotemporal dementia or Alzheimer’s disease. We propose to develop a novel therapeutic strategy using niacin to activate the HCAR2 receptor and stimulate a protective neuroimmune response to tau pathology. The present study is directed at the identification and development of an effective therapeutic strategy that can limit tau pathology.